TEXAS ANIMAL FEED REGULATORY PROGRAM STANDARDS DEVELOPMENT AND MAINTENANCE OF THE ANIMAL FEED REGULATORY PROGRAM STANDARDS FLEXIBLE FUNDING MODEL COMPLIANCE AND ENFORCEMENT EXPANSION SUPPLEMENT

Abstract:
Texas Animal Feed Regulatory Program Standards Development and Maintenance of the
Animal Feed Regulatory Program Standards Flexible Funding Model Compliance and
Enforcement Expansion Supplement
The Office of the Texas State Chemist (OTSC) is the designated state agency that oversees the
regulation of animal feed including sample analysis. Specifically, OTSC is comprised of the Texas
Feed and Fertilizer Control Service (FFCS) which is the regulatory agency and the Agricultural
Analytical Service (AAS) which analyzes regulatory samples for FFCS and the Food and Drug
Administration. OTSC has fully implemented the eleven standards, achieved ISO 17025:2017
accreditation, created a document management system, is utilizing the system for AFRPS
implementation, and is participating in the Lab Flexible Funding Model for chemical and
microbiological surveillance. The FFCS is taking enforcement action on positive samples detected
during the LFFM project. During the next 3 years, OTSC will more fully integrate AFRPS through
a number of activities including exploring how the PCAF regulations could be incorporated into
Texas Commercial Feed Rules, building a more robust facility risk ranking matrix and analysis
platform, expanding audits to focus on PCAF and CGMP inspections, utilize feed-related illnesses
or death data in the risk ranking matrix, continue to evaluate industry compliance through the
enforcement matrix, expand outreach content and audience and incorporate Laboratory Flexible
Funding Model program samples into the OTSC annual plan of work. OTSC will expand
compliance activity as part of this Cooperative Agreement Program. This includes hiring an
additional program coordinator who will assist compliance including traceability for all positive
samples. As a new hire, this individual will need substantial training in year one by the OTSC
Associate Director of Compliance, participation in FDA educational programs, and traveling in the
state to assist in performing inspections and compliance activities. These will be entered into a
feedback loop to continually improve the performance by OTSC in fulling compliance obligations
within the LFFM and lead to improved feed industry corrective actions including performing root
cause analysis and implementing steps toward continuous improvement in adopting hazard
analysis and risk-based preventive controls for food for animal contained within the Food Safety
Modernization Act regulations and guidance.

Public health relevance
Narrative: Texas Animal Feed Regulatory Program Standards Development and Maintenance of the Animal Feed Regulatory Program Standards Flexible Funding Model Compliance and Enforcement Expansion Supplement During the next 3 years, OTSC will more fully integrate AFRPS through a number of activities including exploring how the preventive controls for animal food regulations could be incorporated into Texas Commercial Feed Rules, building a more robust facility risk ranking matrix and analysis platform, continue to evaluate and achieve industry compliance through the enforcement matrix, and incorporating Laboratory Flexible Funding Model program samples into the OTSC annual plan of work. OTSC will expand the number of qualified individuals to perform product traceability and assist firms perform root cause analysis and take corrective actions involving contaminated product identified by the OTSC lab as part of LFFM..